Neighborhood characteristics, GPS-based activity space, and cognitive health

Project Summary/Abstract

The Pathway to Independence Award will help launch Dr. Jinshil Hyun’s independent research career
focused on environmental/behavioral factors that modify trajectories of cognitive aging and Alzheimer’s
disease and associated dementia (ADRD). Her proposed aims use geospatial and GPS-based methods to
comprehensively characterize the impact of neighborhood on cognitive health. Her K99 training has
supplemented her expertise in ambulatory cognition and cognitive aging with a foundation in neuroepidemiology (Dr. Lipton), spatial analysis and urban health (Dr. Lovasi), and biostatistics (Dr. Hall). The
K99/R00 research leverages rich dataset from the Einstein Aging Study and existing resources at the Albert
Einstein College of Medicine. The findings from this study will identify person- and contextual-level risk profiles
for ADRD, which will ultimately support policy suggestions and interventions to promote cognitive health in late
life, especially among vulnerable populations.
There have been important advances in our understanding of risk and protective factors for ADRD,
including studies that explore the impact of neighborhood environments on cognition. Although most studies
used data from objective measures of geospatially-defined neighborhoods, individuals’ perception of their
neighborhoods and person-specific experience of neighborhood environments may vary among individuals
even within the same area. This project aims to investigate the influence of neighborhood characteristics,
assessed by (i) objective, geospatially-defined and subjective neighborhood aspects and (ii) GPS-based,
person-specific activity space measures, on cognitive decline, ADRD, and cognitive health disparities. The PI
processes and analyzes data collected from the Einstein Aging Study’s annual ecological momentary
assessments battery. Continuous GPS tracking from smartphones allows to characterize person-specific
neighborhood experiences (i.e., activity space). Cognitive outcomes are measured by both yearly conventional
neuropsychological tests and smartphone-based ambulatory assessments (6x/day) over 14-day burst data
collection periods each year of follow-up. In the K99 phase, the PI examined how objective and subjective
neighborhood aspects were associated with cognitive outcomes (Aim 1). In this phase, the PI also obtained
training in spatial analysis, and based on that, processed GPS data and developed activity space measures. In
the R00 phase, the PI will examine the associations of GPS-based activity space with cognitive and brain
health (Aim 2), and subgroup (e.g., biological sex, race, APOE e4) differences in the associations (Aim 3).
Aims 1 to 3 results will provide the basis for an R01 application in the second award year of the R00 phase.
Keywords: activity space, neighborhood, urban health, GPS, Geographic information system, spatial
analysis, ecological momentary assessments, ambulatory cognition, cognitive aging, ADRD, disparities.

Public health relevance
Project Narrative This project aims to examine the influence of contextual-level neighborhood characteristics and person-specific neighborhood experiences on trajectories of cognitive aging and Alzheimer’s disease and related dementias. The study will also examine neighborhood factors influencing cognitive health disparities. The expected outcomes will guide sustainable behavioral interventions and population-level interventions to promote cognitive health especially among vulnerable populations.